PROGRESSION AND RISK MARKERS OF EARLY ONSET PERIODONTITIS

Early-onset periodontitis is a disease characterized by a progressive loss of the tooth supporting tissues in adolescents and young adults. This study was undertaken to study the pattern of progression of this disease and to identify potential risk factors. Adolescents with early-onset periodontitis were identified within a population of 14,000 pupils in grades 8 to 12 examined by a national survey of the oral health of US children conducted by NIDR during the 1986/87 school year. A group of controls were matched to disease cases on gender, race, age, geographic location and metropolitan status. The cases and controls were followed over a period of 6 years during which clinical measurements were undertaken to monitor the attachment loss, caries, dental fillings, gingival inflammation and local plaque retaining factors. The analyses are underway to assess the potential of clinical factors in discriminating between the cases and the controls.